BBDC RDCRN Administrative Core

PROJECT SUMMARY (BBDC Administrative Core)
The BBDC administrative core will coordinate and implement the BBDC under the direction of the overall PI
Dr. Brendan Lee, co-PI Tracy Hart, and Clinical Team Liaison Dr. V. Reid Sutton. It will also coordinate the
interactions among the clinical sites, cores, and the patient advocacy site. To achieve this, the Core will track
and facilitate funds transfer and subcontracts between participating sites, schedule and prepare agendas for
monthly teleconferences separately for the executive committee, the PI-steering committee, and site
coordinators. The Core will coordinate the annual BBDC in person meeting in conjunction with the annual
Osteogenesis Imperfecta Foundation Scientific Meeting, and facilitate the annual Geisman training fellowship
competition. Finally, the core will administer and review a) clinical training fellowships by the OIF, b) pilot
project applications, c) requests for access to bio-specimens collected within the longitudinal study, d)
centralized radiographic reading and quality/assessment of imaging sites, and coordinate e) the annual
external advisory committee review and f) administrative preparation of documents for single Institutional
Review Board (sIRB) and Data and Safety Monitoring Board (DSMB) review. The Core will be responsible for
all communications between the BBDC and the broader RDCRN and Participant communities.

Public health relevance
PROJECT NARRATIVE (Administrative Core) The Administrative Core (AC) will be the hub for administering all aspects of the BBDC. It will facilitate implementation, communication, and reporting of the clinical projects, the career enhancement core, the biostatistics core, and the pilot/feasibility core. It will also facilitate interaction with the NIH, DMCC, and DSMB.